Impact of hemodynamics on efferocytosis in endothelial cells

PROJECT SUMMARY/ABSTRACT
Flowing blood generates a frictional force called shear stress that plays an important role in endothelial
dysfunction and atherosclerosis. Branches and bends of arteries are exposed to low and disturbed flow (d-flow),
a mechanical environment that promotes vascular dysfunction and atherosclerosis. Conversely, physiologically
high shear stress generated from steady laminar flow (s-flow) is protective. Helical flow (h-flow) associated with
advanced shear stress exists not only in the ascending aorta but also in other parts such as the right coronary
artery, descending aorta, common iliac artery, and common femoral artery. H-flow may have several positive
physiological roles, such as suppressing/eliminating areas of flow stagnation, preventing the accumulation of
atherogenic lipids on the luminal surfaces of arteries, and enhancing oxygen transport from the blood to the
arterial wall. Endothelial cells (ECs) are critical sensors of the shear stress that contributes to atherosclerosis.
Efferocytosis is a process by which apoptotic tissue is recognized for engulfment by phagocytic cells, such as
professional phagocytes (e.g., macrophages and immature dendritic cells) and non-professional phagocytes
(e.g., ECs, epithelial cells, fibroblasts, and some stromal cells). Defective efferocytosis in macrophages promotes
advanced atherosclerosis. However, the mechanisms by which shear stress environments regulate EC
efferocytosis and its implications in atherosclerosis remain largely unknown. The central hypothesis to be tested
in this project is that blood flow patterns regulate EC efferocytosis and subsequent endothelial dysfunction and
contribute to the development of atherosclerosis. Our long-term goal is to dissect the relationship between blood
flow patterns and EC efferocytosis and its role in the development of atherosclerosis. Our specific aims are Aim
1- Define the role of blood flow patterns in EC efferocytosis and endothelial dysfunction, Aim 2- Determine the
role of MerTK in endothelial mechanotransduction, and Aim 3- Evaluate the contribution of EC efferocytosis in
atherosclerosis. Defining the mechanisms of efferocytosis regulation will be necessary to target endothelial
mechanotransduction and subsequent endothelial dysfunction. The proposed research is innovative in the sense
that we will connect blood flow patterns, EC efferocytosis, and endothelial mechanotransduction. We will also
evaluate the novel mechanism of EC efferocytosis and its contribution to atherosclerosis.

Public health relevance
PROJECT NARRATIVE Shear stress is a blood flow-associated frictional force that regulates many vascular functions such as inflammation response, vascular permeability, and leukocyte adhesion, all of which are key factors in atherosclerosis. Both clinical and basic data demonstrate that failure in the clearance of dying cells from the body (defective efferocytosis) is linked to atherosclerosis-related events. How blood flow patterns affect efferocytosis in endothelial cells, the cells that line arteries, is largely unknown. Upon conclusion of this study, we will understand the role of blood flow patterns-related defective efferocytosis in endothelial cells, and this discovery will stimulate a new avenue in the design of drugs that treat atherosclerosis by enhancing efferocytosis in endothelial cells or introducing helical flow.